Reverse Engineering of Cell Senescence

Abstract
Cellular senescence is not just a symptom of aging, but a contributor to aging pathologies. Recent
experiments in the mouse show that elimination of senescent cells (a.k.a. senolysis) can reverse several
features of the aging process and extend life- and health-span. This has stimulated interest in cell senescence
and in finding ways to suppress it that can be easily ported from mouse to human and made even more
effective. This implies looking for such drugs as an early senolytic candidate – a kinase inhibitor dasatinib,
whose mode of action is unclear. Taking senolytic therapies into human will also require a better
understanding of the cell type specific progression towards senescence and diverse sub-types of senescence.
In addition to aging per se cells respond to insults such as DNA damage, cell cycle arrest or oncogene
activation by expressing aging phenotypes, such as hypertrophy, cell cycle arrest markers, and by secreting
growth factors and chemokines, which are thought to produce degenerative responses in nearby cells.
Hypertrophy may be one of the most pervasive senescent cell responses but has been hard to study, as until
recently we have not had accurate enough means to measure cell mass and cell size, protein and lipid
content. Yet, hypertrophy is of special interest because it is deeply connected to cell growth, which is
normally under strict control in normal cells. We propose to study how cells, prompted by stressors like
radiation or drugs or simply by age, become hypertrophic and how they come to express senescence markers.
We have three goals: 1) to trace the progression of cell senescence in molecular terms by quantitative mass
spectrometry and phospho-mass spectrometry, and in physiological terms by Raman microscopy, 2) to
identify protein circuits responsible for cell senescence, and 3) to find drugs that will prevent, reverse, or
eliminate senescent cells. As our tools of perturbation, we have chosen kinase inhibitors. Employing a
machine learning approach, we will probe senescent cell development and senescent cell viability via a small
set of well-characterized poly-specific kinase inhibitors; then regress a phenotype, such as senescence-
specific signaling and senescent cell formation or death, to the activity of key kinases and their downstream
circuits. Kinases implicated that way will be independently validated using siRNA knock downs and CRISPR.
Additionally, extensive phospho-proteomic profiling will identify the phosphorylation sites on key proteins
that most contribute to the phenotypes of senescence and which could be druggable by other means. Taken
together, these methods will produce insight into the mode of action of already identified senolytic drugs
and suggest new targets and new drugs for seno-therapies. This combination of pharmacology, machine
learning, quantitative proteomics and new forms of microscopy can provide fresh insights into aging and
suggest potential therapies for aging-related disease.

Public health relevance
Project Narrative Researchers have discovered new types of cells, called “senescent cells”, that are suspected to be involved in aging. We plan to use novel technologies we developed to find out how these cells develop, how they damage normal tissues, and how to kill them.